Role of DNA polymerase eta in errorfree bypass of DNA lesions & cancer prevention

DESCRIPTION (provided by applicant): Translesion synthesis (TLS) DNA polymerases (Pols) promote replication through DNA lesions. Eukaryotic TLS Pols display a high degree of specialization in their proficiency for replicating through different types of DNA lesions. Among these Polη is unique in its proficient ability for error-free replication though UV induced cyclobutane pyrimidine dimers (CPDs), and inactivation of Polη in humans causes the cancer- prone syndrome, the variant form of xeroderma pigmentosum (XPV). Polη also promotes proficient and error-free replication through DNA lesions induced by chemical carcinogens and DNA adducts formed from the action of reactive oxygen species. To elucidate the role of Polη in lesion bypass, we will use a combined biochemical, genetic, and structural approach to determine how Polη mediates proficient and error-free replication through DNA lesions such as a UV induced cis-syn TT dimer, an 8-oxoguanine formed from oxidative damage, and a cisplatin G-G crosslink formed upon cisplatin chemotherapy. In Aim 1, we will determine Polη's mechanism of nucleotide incorporation by a comparison of binary and ternary structures with undamaged DNAs. The structures will be tested by mutagenesis and kinetic studies aimed at defining the reaction pathway of this unique polymerase. In Aim 2, we will determine structures of Polη in ternary complex with DNAs containing a cis-syn T-T dimer, a (6-4) TT photoproduct, an 8-oxoguanine, and a cisplatin G-G intrastrand crosslink. We hypothesize that Polη differs from classical as well as other TLS polymerases in the openness of its active site cleft, enabling it, for example, to accommodate both Ts of the T-T dimer. The structures will tested by biochemical and genetic methods aimed at defining Polη's action on DNA lesions. In Aim 3, using biophysical and biochemical approaches, we will test the hypothesis that even though most of the missense mutations in XP-V patients lie distant from the active site, they adversely affect Polη structure and function because of their effects on the structural stabilities of Polη domains. Together, the studies we propose here will make an important contribution toward delineating the mechanisms by which Polη guards cells against the genotoxic effects of sunlight-induced chromosomal damage as well as damage induced from endogenous oxidation reactions and by chemotherapy. The proficient ability of Polη for mediating error-free replication through DNA lesions formed from exposure to environmental and chemical carcinogens and from cellular oxidative reactions will have a major impact on genome stability by keeping the rate of mutations low, reducing thereby the incidence of carcinogenesis in humans. The proposed studies are highly relevant for cancer biology and etiology, as they will reveal how Polη minimizes the mutagenic and carcinogenic potential of DNA lesions in human cells. PUBLIC HEALTH RELEVANCE: DNA polymerase η (Polη) promotes proficient and error-free replication through DNA lesions. Hence, inactivation of Polη in humans causes the cancer prone syndrome, the variant form of xeroderma pigmentosum. The proposed studies will elucidate the molecular basis of Polη's action opposite different types of DNA lesions.

Public health relevance
Using no more than two or three sentences, describe the relevance of this research to public health. In this section, be succinct and use plain language that can be understood by a general, lay audience. DNA polymerase h (Polh) promotes proficient and error-free replication through DNA lesions. Hence, inactivation of Polh in humans causes the cancer prone syndrome, the variant form of xeroderma pigmentosum. The proposed studies will elucidate the molecular basis of Polh's action opposite different types of DNA lesions.